A non-human primate model for bimanual touch

PROJECT SUMMARY/ABSTRACT
Primates use their hands together or independently, so the nervous system must support flexible sensory
modes to coordinate signal processing from the two hands. Conceivably, specialized circuits exist to
coordinate central processing of sensory inputs from the two hands (bimanual touch), resembling dedicated
mechanisms supporting binocular vision and binaural hearing. Prior efforts have focused primarily on
understanding somatosensory processing on a single hand, so how the nervous system supports bimanual
touch is essentially unknown. The long-term goal of this research program is to establish an understanding of
how bimanual touch signals are encoded and elaborated in the primate brain. Because human and non-human primates (NHP) share the ability to sense touch using their hands, NHP are an ideal model for studying the neural constructs of touch. The immediate goal of this project is to establish an experimental platform for
manipulating and measuring bimanual perception and neural coding in NHP. The proposed work combines
behavior and neural recordings in macaque monkeys. The first aim of the work is to investigate how monkeys
perceive tactile cues presented on two hands. We will leverage a paradigm that has previously revealed
bimanual perceptual interactions in humans. The second aim of the work is to investigate how neural
populations in primary somatosensory cortex (S1) represent bimanual touch. These experiments are premised
on prior work showing that S1 neural activity to stimulation on the contralateral hand can be modulated by
stimulation on the ipsilateral hand. We will test the hypothesis that bimanual interactions in S1 are context-
dependent by characterizing how the animal’s use of the tactile cues determines S1 responses to bimanual
touch. Significance: The proposed work will unveil novel correspondent sensibilities between NHP and humans
to establish a tractable model for investigating the neural basis of bimanual touch. Establishing how ipsilateral
and contralateral hand signals interact in S1 can inform a conceptual framework for understanding the
functional role of bimanual neurons in higher-order somatosensory regions and how the somatosensory
system supports flexible sensory behavior. Broad Impact: This project lays the groundwork for future
investigations on how bimanual signals are combined or segregated in the primate brain to mediate perception
and motor function. This may yield insight into developmental and psychiatric disorders that are characterized
by aberrant sensorimotor processing such as ADHD, ASD, and schizophrenia. A network-level understanding
of somatosensory communication can inform how sensorimotor functions changes with aging and age-related
cognitive decline. Crucially, this work will inform the design of bimanual neuroprostheses to restore dexterous
hand function in those who has lost it.

Public health relevance
PROJECT NARRATIVE This project is aimed at understanding how non-human primates perceive touch using their two hands and how neurons encode bimanual touch signals. Our findings will establish a model system for investigating bimanual neural coding. The long term goal of this research is to discover neural coding principles that can inform the design of therapies for restoring hand function individuals who has lost it.